Patient Care Core

CORE A: Patient Care Core The purpose of Core A is to coordinate and facilitate all the patient based research in this Program Project, arranging for patients to have selected tests at intervals that maximizes research testing while not disrupting the clinical care of any subject. This Core is responsible for arranging with patients convenient dates for appointments for clinical care, and organizing any research blood testing and obtaining samples for the laboratories of the participating investigators. Core A also coordinates the visits of patients pertinent to this program, who are traveling to Rockefeller Hospital so that blood or other samples can be shared with the investigative team. This Core also arranges for the submission of cells or other materials obtained, to the facilities of Core B, for cell phenotyping and/or cell isolation, and the establishment of cell lines as needed. This Core is responsible for obtaining cells, or other patient materials from outside sources as needed. This Core is also responsible for maintaining and updating all IRB and HIPAA materials and to obtain patient consents for all procedures. This Core will therefore continue to support Projects 1-4 in this ongoing Program Project.

Public health relevance
Patient Core A is required to coordinate patient recruitment while not impeding clinical care, so that research work is carried out under correct IRB protocols, confidentiality is maintained, and Project Leaders and other involved investigators and laboratories are aware of patients coming for clinic visits in a timely manner. Core A coordinates the collection of all materials obtained during clinic visits, or that are shipped, with Core B in a de-identified manner, in order to maximize the use of all samples